GENETIC MAPPING OF NEUROLOGICAL DISEASE (FAMILIAL ATAXIAS)

The familial ataxias are neurological genetic disorders characterized by increasing clumsiness or ataxia. This is a study of forms of genetic ataxia in individuals in whom the disease gene(s) have not been previoulsy characterized. The purpose of this study is to isolte and identify these disease producing genes and determine how they cause ataxia.